Cell Specific RIPK3 Signaling After Traumatic Brain Injury in Mice

Receptor interacting protein kinases (RIPK)-1 and -3 are serine-threonine kinases that regulate apoptosis,
necrosis, and inflammation. RIPKs mediate programmed necrosis via RIPK1-RIPK3-MLKL necrosome
assembly, and apoptosis via the ripoptosome involving FLIP, caspase-8, TRADD, and RIPK3, among others.
RIPK1 inhibitors are currently in human clinical trials for several systemic diseases. In contrast, RIPK3 has
been less studied in part because clinically acceptable RIPK3 inhibitors are not yet available. Building on our
prior studies showing improved neurological outcome in mice deficient in TNF and Fas receptor (upstream
activators of RIPK3), we used genetic tools to interrogate a possible role for RIPK3 in a mouse controlled
cortical impact (CCI) model. Mice lacking RIPK3 had improved motor and cognitive function after CCI, and
greater protection in cognitive function tests than RIPK1 kinase dead or MLKL knockout mice, suggesting a
unique role for RIPK3- independent of necroptosis because acute neuronal cell death or lesion volume was not
reduced by RIPK3 knockout. Using immunopanning to isolate specific brain cell populations, we found the
highest levels of RIPK3 expression in endothelium and immune cells. RIPK3 KO mice had reduced HMGB1
release after CCI, reduced interleukin-1 beta processing in brain tissue and endothelial cells, and maintained
K48 ubiquitination of neuronal proteins and brain TBK1 levels- mechanisms that have previously been shown
to modulate outcome after CCI and contribute to neurodegeneration in aging-related neurodegenerative
diseases. We hypothesize that RIPK3 signaling in endothelial and immune cells induces neurological
dysfunction after cerebral contusion by activating multiple acute inflammation pathways and is a potential
therapeutic target to improve outcome. To test this hypothesis we propose three specific aims: Aim 1, to
identify upstream mechanisms regulating RIPK3 activation in specific brain cell types after CCI in mice, using
immunopanning and FACS to isolate specific brain cell types; Aim 2, to define cell-specific functional roles for
RIPK3 in brain vs. peripheral immune cells using bone marrow chimeras and inducible/conditional RIPK3
knockout mice; and Aim 3, to identify mechanisms downstream of RIPK3 that might contribute to
neurodegeneration in the chronic period after TBI.

Public health relevance
Work in the proposed project could render a new mechanism of secondary injury for patients with traumatic brain injury. In the long term, the proposed experiments could lead to new therapies targeting receptor interacting protein kinase-3 function or its related pathways, and thereby improve quality of life of TBI survivors.